Harnessing EHR-linked Genomics Data to Study Clonal Hematopoiesis and its Evolution to Inflammatory Phenotypes

Project Summary
Clonal hematopoiesis (CH), a genetic mosaicism which occurs after hematopoietic stem/progenitor cells acquire
one or more mutations, is a common phenomenon associated with aging, affecting between 10-30% of
individuals aged 70 and older. Although there is substantial overlap between the mutations seen in CH and those
seen in hematologic cancers, individuals with CH often have normal blood counts. However, harboring a clone
is not harmless – a growing body of research has demonstrated that CH is associated with 1) increased all-
cause mortality, 2) a ten-fold higher rate of leukemic transformation, and 3) a doubling of the risk of ischemic
cardiovascular events, which independent mouse models have shown to be linked to a CH-mediated increase
in inflammation. That only a subset of individuals with CH go on to have a myocardial infarction or develop
leukemia raises the question of how germline and environmental factors shape clonal outgrowth and phenotypic
consequences. This proposal seeks to investigate a specific germline-somatic-phenotype interaction through
identification of CH within a unique Vanderbilt University Medical Center resource: a large genetic database
(BioVU) linked to a complete, de-identified version of patients’ electronic health records (EHR). The basis for this
work rests on the more than 90,000 individuals within BioVU who have been genotyped on the same single
nucleotide polymorphism (SNP) array. In preliminary data presented in this proposal, it is shown that this
germline genotyping array can be used to detect the somatic variant JAK2V617F, a mutation common in both CH
and myeloproliferative neoplasia (MPN), with a high degree of accuracy for variant allele fractions (VAFs) > 5%.
Aim 1 of the proposed studies will expand this computational approach to identify somatic mutations to other
common CH lesion sites and validate its effectiveness. Existing array data will be used to define SNP-specific
and generalized cutoff values to differentiate putative somatic mutants from germline variants. Digital PCR will
then be used to determine the accuracy of this approach and to define its limit of detection for JAK2V617F and
other CH mutations. Aim 2 of these studies will seek to demonstrate the utility of these methods by investigating
a possible mechanism by which germline SNPs associated with higher rates of somatic JAK2V617F mutations
influence the progression to JAK2V617F-positive MPN. Data presented in the proposal identify an immune-
associated protein predicted to be highly expressed in cells with these JAK2V617F-associated germline SNPs.
These studies will elucidate the target’s contribution to inflammation via in vitro overexpression studies utilizing
human cell lines and primary hematopoietic cells and will correlate target protein expression with MPN diagnosis
and progression through chart review. Together, these studies will characterize the contribution of a germline-
induced proinflammatory state to JAK2V617F clonal outgrowth and will establish a tool for studying the influence
of germline and environmental exposures on CH acquisition, progression, associated comorbidities, and
mortality.

Public health relevance
Project Narrative Clonal hematopoiesis is an age-related process affecting 10-30% of the elderly that is associated with increased risk of death, leukemia, and heart attacks. This work seeks to understand how inherited traits may alter the likelihood that an individual with clonal hematopoiesis experiences an adverse outcome by looking at genomic data linked to electronic medical records. The tools and insights generated in this work may improve the identification of individuals with clonal hematopoiesis at the highest risk of developing disease, information that could enhance the utility of disease-preventing measures in the future.